Understanding the effect of post-concussive sleep disruption on glymphatic function in collegiate athletes

Project Summary:
Up to 4000 collegiate athletes annually sustain a concussion in the United States. Sleep-wake disturbance
(SWD) is one of the most common complaints following a concussion. Athletes who report post-concussive
SWD also report worse somatic and cognitive impairment and a longer recovery time. Unfortunately, the
current therapies aimed at improving sleep in patients with concussions are limited by poor compliance and
low efficacy. Our long-term goal is to target post-concussive SWD as an independent, modifiable risk factor for
poor outcomes in collegiate athletes and other at-risk populations. In this study, we aim to answer two
fundamental questions. First, among student-athletes, who is at risk for developing post-concussive SWD?
Second, what are the biological mechanisms linking post-concussive SWD and poor outcomes? Answering
those questions will advance our field by 1) allowing early identification of at-risk subjects and 2) establishing
therapeutic targets for the thousands of patients who, despite their best attempts, still struggle with poor sleep
following a concussion. This proposal focuses on the glymphatic pathway as a potential biological link between
post-concussive SWD and poor outcomes. The glymphatic pathway is a network of perivascular spaces that
supports the clearance of cerebral interstitial molecules and wastes during sleep. In animal models,
concussion and sleep restriction impair glymphatic function, worsening neurological function. However, the
combined effects of concussion and post-concussive SWD on glymphatic function in humans remain unknown.
We hypothesize that concussion and post-concussive SWD have a multiplicative impact on glymphatic
function impairment (i.e., a 'double hit' mechanism). We use magnetic resonance imaging (MRI) to
measure human perivascular spaces. The number and volume of these structures (i.e., their burden) have
been proposed as a surrogate marker of glymphatic function. In addition, we recently developed other MRI
modalities to assess different facets of glymphatic function. To test our hypotheses, we will track sleep in a
cohort of collegiate athletes during the sports season using actigraphy and a contactless bed mat sensor. We
will also obtain a polysomnogram and an MRI fourteen days post-injury in those with a concussion and controls
with musculoskeletal injuries. We will use advanced neuroimaging techniques to measure various aspects of
glymphatic function, including perivascular space burden, contrast clearance, water diffusion, and slow
vasomotor oscillations. We propose the following aims: in collegiate athletes, 1) define the pre-morbid risk
factors for developing post-concussive SWD; 2) establish the combined effects of concussion and post-
concussive SWD on perivascular space burden; 3) determine the association between post-concussive SWD
and non-invasive, clinically available neuroimaging markers of glymphatic dysfunction. Results from this study
may help identify at-risk subjects and provide the rationale for targeting glymphatic function (pharmacologically
or via other interventions) to prevent post-concussive morbidity in athletes and other populations.

Public health relevance
Project Narrative: This proposal aims to understand how post-concussive sleep disruption impacts recovery in collegiate athletes with a concussion. We will use advanced neuroimaging techniques to study how sleep disruption affects the glymphatic pathway, a network of channels associated with cerebral waste removal during sleep. Our study's findings will lay the foundation for interventions to improve recovery from concussions, which affect thousands of athletes annually.